Hormones and Genes in Women's Health: From Bench to Bedside

PROJECT SUMMARY/ABSTRACT
Women and men are at different risks for the onset, expression, and treatment response in a number of
disorders that occur at different stages of the lifespan, from development through aging. The mechanisms that
explain these sex differences or disorders specific to women are still unclear. The mission of our Harvard
BIRCWH is to develop the next generation of scientist-clinicians as leaders in the field of women’s health who
will contribute to understanding sex-dependent vulnerabilities to clinical disorders and those disorders specific
to women. This administrative supplement application seeks to recruit a 4th BIRCWH Scholar to increase our
representation of Scholars who are underrepresented in medicine in our Harvard BIRCWH integrated
interdisciplinary training program. The program is modeled in the context of a lifespan perspective to identify
etiologic mechanisms during fetal development, puberty, adulthood, and aging, with some focus on female-
specific periods such as child-bearing years and menopause. Further, an underlying assumption of our
BIRCWH program is that an understanding of the role of hormones and genes will provide the basis for
understanding sex-dependent vulnerabilities to clinical disorders. The Division of Women’s Health at Brigham
and Women’s Hospital (BWH) is and will continue to be the home site for this endeavor, in the broader context
of a Harvard-wide training program. The program capitalizes on the long tradition of interdisciplinary research
in women’s health with Mentors who already collaborate across institutions at BWH, Massachusetts General
Hospital, Beth Israel-Deaconess Medical Center, Boston Children’s Hospital, Dana Farber Cancer Institute,
McLean Hospital, Harvard School of Public Health, Harvard Medical School and the Eli & Edythe Broad
Institute. Each of the two Scholars is assigned a team of Mentors in order to operationalize the concept of
training Scholars to think in a translational manner. Primary Mentors are in clinical or basic research and
provide the site at which the Scholar works. Secondary Mentors are in basic or clinical research (as a
counterpart to the Primary) and help to guide thinking, suggest coursework, and readings, depending on the
Scholar’s interests. Career Mentors advise Scholars in the relevant departmental and academic structures for
career advancement. Mentors in Health Disparities expose Scholars to thinking about how the roles of
hormones and genes in predicting morbidity are influenced by socioenvironmental factors. The Harvard
BIRCWH program focuses on the following disorders, given either their known higher incidence and/or
differential expression in women than men and the strengths of the Harvard community in women’s health:
Cardiovascular Disorders; Reproductive Endocrine & Neuroendocrine Disorders; Neuropsychiatric Disorders;
Autoimmune Disorders; and Female Cancers. By capitalizing on the vast resources and faculty at Harvard, we
believe that Harvard is an ideal site for continuing to offer an integrated, interdisciplinary and truly translational
program that is training the next generation of leaders in women’s health.

Public health relevance
PROJECT NARRATIVE Although there are significant sex differences in the expression and onset of major medical and psychiatric disorders, clinical decisions based on research are primarily based on data from men and may often be inappropriate for women. Thus, there is a strong need for the education, training, and development of junior investigators who will commit their careers to studying the impact of sex and gender on clinical disorders. Their research programs will provide the basis for the development of sex-dependent treatment approaches and public awareness of the importance of these sex-dependent health issues for families and society.